Hepatitis C Drives Neuropathogenesis in HIV/HCV Coinfection Patients

DESCRIPTION (provided by applicant): When studying individuals who are infected with HIV and HCV, we found greater cognitive dysfunction in those who were coinfected (HIV/HCV) than in individuals with either viral infection alone. There is a large population of coinfected individuals who are HCV viremic and yet maintain HIV below 50 copies/ml through effective viral suppression with antiretroviral therapy (ART). New data from our laboratory show that coinfected patients are at greater risk for cognitive impairment than either HCV or viral controlled HIV- infected subjects. Our recent findings identified a monocyte type I IFN??response in some coinfected individuals that was absent in both virally suppressed HIV and HCV monoinfected individuals. Importantly, this monocyte activation profile was characterized by the expression of 6 genes that strongly correlated with cognitive impairment in coinfected individuals. Since HIVUD (undetected; <50 copies/ml) was common to both HIV mono- and coinfected individuals, the IFN activation profile in the monocytes was likely due to HCV, suggesting that successful HCV treatment might lower activation and subsequently improve cognition. In the past, the majority of coinfected subjects were not treated with standard HCV therapy due to its low success rate and frequent debilitating side effects. However, new HCV protease inhibitors (PIs) combined with peginterferon/ ribavirin (triple therapy) are an effective treatment that more consistently achieves sustained viral response (SVR). We propose to study coinfected subjects who choose to be treated and evaluate them before and after therapy for monocyte activation and changes in neuropsychological performance. We also propose to explore a mechanistic approach for the viral-induced monocyte activation on neural cell function. We show that monocytes from coinfected subjects shed exosomes containing miRNAs (miRs) that can suppress essential transcripts associated with neural cell-related targets. Our overall hypothesis is that reducing th immune activation profile by clearing HCV with treatment in coinfected individuals will result in cognitive improvement and a decrease in M/MΦ immune-activating miRs. Successful completion of this work will validate our peripheral monocyte markers of immune activation in coinfection that correlate with cognitive impairment plus mechanistically show how coinfection adversely affects neural cell function through activated monocyte-derived exosomal miRs.

Public health relevance
PUBLIC HEALTH RELEVANCE: Coinfection with HIV/HCV is associated with severe liver damage and increased psychological problems; however, it is difficult to treat. We identified a blood monocyte activation profile that correlated with cognitive impairment in coinfected people. We propose to study how successful treatment of HCV in people with controlled HIV will return to psychological health. We also propose experiments to determine how HCV affects the brain __SpecificAimsTextDelimiter__ This is a renewal of a 3-year R01 where HIV/HCV-infected (coinfected) subjects were assessed for cognitive impairment and peripheral immune activation. We found that 60% of coinfected subjects were cognitively impaired which was significantly higher than subjects that had either HCV or HIV monoinfection. Since neither HCV nor HIV directly infects neurons, these defects are presumably mediated by systemic inflammatory signals. Successful HIV suppression using antiretroviral therapy (ART) can reverse or prevent neurocognitive changes in patients infected with HIV alone but the contribution of HCV coinfection toward HIV associated neurologic morbidity has not been clearly defined. In the prior funding period, we identified a possible link between disease-specific changes in cognition and discrete activation profiles in peripheral monocytes from coinfected subjects. Using microarray expression analysis, we found that productive HIV infection triggers a predominant "alarm" signature in peripheral blood monocytes characterized by type I IFN stimulation, whereas chronic HCV induces a discrete "HCV-specific" pattern without a predominant type I IFN signature. In HIV monoinfected patients, viral suppression with undetectable viral load on ART was associated with normal cognition and with monocyte signatures that were indistinguishable from those of normal control subjects. Interestingly, coinfected subjects also expressed the monocyte 'alarm" pattern of type I IFN stimulation, despite the absence of detectable serum HIV. Among coinfected patients, impaired cognition correlated statistically with the elevated expression of six monocyte genes of which five were associated with a type I IFN response, even among those with suppressed serum HIV viremia. These data suggest a hitherto unappreciated influence of HCV coinfection upon impaired neurocognition and monocyte activation during HIV infection, even in the setting of HIV viral suppression using ART. Moreover, they suggest that ART alone might not be adequate to prevent or reverse HIV-associated neurocognitive morbidities in the presence of HCV coinfection. In this proposal, we will enroll treatment and control subjects into a protocol to clear HCV using a highly effective regimen consisting of an HCV protease inhibitor in addition to pegylated-IFNα/ribavirin. We anticipate that, among coinfected subjects who eradicate HCV, monocyte activation will be suppressed and cognitive scores will improve. We shall also explore potential mechanisms for cognitive impairment during confection, including those by which activated monocytes can alter functions in neural cells, including a mechanism whereby shedding of monocyte/macrophage (M/MΦ) exosomes transmit regulatory miRNAs (miRs) that may impact essential neural cell functions in HIV/HCV coinfection. Our Overall Hypothesis is that monocyte activation is responsible for cognitive impairment in coinfection and lowering activation will improve cognition. Our Specific Aims are to: 1. In a longitudinal study, determine if HCV eradication in coinfected individuals decreases chronic immune activation and improves cognition 2. In a cross-sectional study, confirm targeted monocyte genes and identify plasma markers linked to immune activation and cognitive impairment in coinfected subjects 3. Investigate a possible mechanism for impaired cognition in coinfected subjects that involves shedding of activated monocyte-derived exosomes harboring miRs that target neural cell dysfunction